Therapeutic Potential of a Novel MGMT-Dependent DNA Interstrand Crosslinking Agent in the Treatment of DNA Repair Deficient Cancer

PROJECT SUMMARY/ABSTRACT
Defects in DNA repair are prevalent in human cancer and present an opportunity for targeted tumor treatment
with agents that induce DNA damage only in cells with specific DNA repair defects. O6-methylguanine-DNA
methyltransferase (MGMT), a direct reversal repair enzyme that removes O6-alkylguanine lesions deposited by
alkylating agents such as temozolomide (TMZ), is the most frequently silenced DNA repair gene in cancer, with
promoter hypermethylation observed in ~10% of all tumors. Loss of MGMT occurs in the majority of lower grade
gliomas, ~50% of glioblastomas (GBM), and in a broad array of other cancer types, including ~20-40% of colon
cancer and melanoma. MGMT is ubiquitously expressed in normal tissue, and reduced MGMT expression in
tumors predicts for clinical benefit from TMZ, owing to the accumulation of DNA damage specifically in tumor
cells. Importantly, the efficacy of TMZ in MGMT-deficient tumor cells is dependent upon intact mismatch repair
(MMR) proteins, and resistance to TMZ arises due to MMR loss in ~50% of recurrent gliomas and ~20% of
recurrent GBM. Strategies are needed to avoid or overcome this major resistance mechanism in order to
therapeutically exploit MGMT silencing in cancer. In recent work, we identified a novel 2-fluoroethylating agent,
KL-50, which overcomes TMZ resistance through the induction of DNA interstrand crosslinks (ICLs) specifically
in tumor cells lacking MGMT, leading to MMR-independent activity in glioma models. We aim here to evaluate
more broadly the therapeutic potential of this targeted DNA modifying agent. We hypothesize that the MGMT-
dependent crosslinking activity of KL-50 can be harnessed to exploit unique combinations of DNA repair defects,
combined with DDR inhibitors (DDRi’s) to enhance therapeutic potential, and utilized to overcome certain
mechanisms of resistance to TMZ, independent of cancer histology. In Aim 1, we will determine the prevalence
of cancers with combined MGMT and ICL repair defects and establish the therapeutic potential of KL-50 in this
subset of cancer. We will characterize the overlap of MGMT and ICL repair defects in a large pan-cancer
database and evaluate the activity of KL-50 in experimental in vitro and in vivo models representing this subset
of tumors, alone and in combination with DDRi’s. In Aim 2, we will analyze resistance mechanisms to TMZ and
KL-50 in MGMT-silenced tumors and determine the ability of KL-50 to avoid or overcome TMZ-induced
resistance in non-glioma tumors. Using colon cancer, melanoma, and pancreatic neuroendocrine tumor cell
models, we will perform focused CRISPR-Cas9 screening and develop drug-resistant cell lines to identify key
resistance factors. Emergence of drug resistance and the ability of KL-50 to target TMZ-resistant tumors will
further be analyzed in patient-derived primary cells and xenograft models. These studies will advance our
understanding of targeted DNA modifying agents and may support the initiation of clinical trials evaluating KL-
50 or related compounds in the treatment of DNA repair deficient tumors.

Public health relevance
PROJECT NARRATIVE DNA repair abnormalities occur frequently across human cancer types, presenting the potential for targeted tumor treatment via synthetic lethal approaches. We recently discovered a novel DNA modifying agent which generates DNA interstrand crosslinks specifically in tumor cells lacking the DNA direct repair enzyme O6- methylguanine-DNA methyltransferase (MGMT) and is effective in temozolomide (TMZ)-resistant glioma models. This proposal seeks to understand the therapeutic potential of this compound in a broader array of MGMT-deficient cancers, specifically by targeting additional defects in interstrand crosslink repair and by circumventing TMZ resistance.